Toward understanding mechanisms of inadvertent lower extremity displacements from wheelchair footplates in Veterans with SCI/D: Multi-modal evaluation of leg movements during power wheelchair use.

Veterans with sensorimotor deficits due to spinal cord injuries and disorders (SCI/D) and other neurological
disorders often use power wheelchairs (PWC) for independent mobility. While PWC are critically important to
improving quality of life, lower limb injuries can occur when the foot is not positioned properly on the footplate
during PWC operation. In Veterans with SCI/D, sensory loss, paralysis, spasticity, contractures and obesity
create barriers to recognizing and correcting lower limb mispositioning. Veterans with SCI/D have sustained
fractures, abrasions, contusions, pressure injuries, and amputations after inadvertent lower extremity
displacements (ILED) from their PWC foot plates, at an estimated system cost of $970,011 for the first 10 such
Veterans admitted to the Cleveland VA SCI/D Center. Veterans Advocates with SCI/D report that ILEDs occur
during transfers, pressure relief, colliding with objects, muscle spasms, and driving over rough terrain. PWC
seating functions, like tilt and leg elevation, may misalign the feet on the footplate when returning to upright.
Yet, there is little documentation of the root cause of lower extremity injuries in the medical record, and ILED
incidence and prevalence are poorly described in the literature. No scientific reports of how the lower limbs
move during WC operation have been identified. This important knowledge can guide interventions to prevent
future foot displacements and subsequent injuries.
The VA-patented FootSafe system of force and proximity sensors with a wirelessly-connected smart device
was developed as an assistive technology to detect foot position relative to the PWC footplates and warn PWC
users when an ILED occurs, thus empowering them to either reposition their legs to safety or call for help if
needed. Other AT solutions also may be possible, however. Therefore, to create useful and accurate sensing
algorithms in future, it is first critical to understand the potential range of ILEDs and whether different PWC
user groups are more or less vulnerable to these events. As noted above, Persons with SCI/D can serve as an
exemplar of PWC users with sensorimotor losses creating risk of ILEDs and subsequent injuries.
This research project will use a 3 pronged approach to understanding lower limb movements and ILED
occurrence during PWC mobility.
Focus groups of Veterans with SCI/D, their caregivers, and seating specialists will be convened to advise on
the ILEDs they are primarily concerned about, how much limb displacement is acceptable and when they feel
corrections are required to prevent harm, to design terrains courses and determine PWC speeds needed to
increase likelihood of capturing ILEDs during testing, and to reach consensus on what constitutes a clinically
significant ILED and the needed sensitivity for detection by future algorithms.
FootSafe will be used in combination with motion capture and depth camera technologies to compare the
biomechanics and kinematics of lower limbs motion during PWC operation by Veterans with SCI/D and
neurologically intact PWC users in laboratory and community settings.
The FootSafe and 3-dimensional data sets acquired during the lab and community PWC mobility phases will
be analyzed using Machine Learning anomaly detection techniques to quantify limb displacements and further
understand how the limbs move over time. Video and wireframe diagrams for detected anomalies will be
brought back to the focus groups for their assessment of the clinical relevance as previously noted.
Understanding how ILED leading to these injuries occur, in what situations of PWC use and by which PWC
users is crucial to solving the problem of ILED-related injuries. Objective ILED documentation will not only
improve development of future assistive technology algorithms to detect and alert PWC users when ILEDs
occur, but will also support payor provision of preventative seating system modifications and promote
development of regulatory guidelines and unique solutions to prevent these unfortunate injuries.

Public health relevance
Wheelchairs give Veterans with paralysis due to spinal cord injury (SCI) freedom to move and better quality of life. Sadly, Veterans using wheelchairs can be injured if they cannot feel or move if their leg or foot falls off or sits wrongly on the wheelchair foot rest. Injuries have included broken legs, pressure ulcers, such bad scrapes that a Veteran’s leg had to be cut off, and one Veteran may have died from severe bleeding due to this while on blood thinners. In this study, we will work with Veterans with SCI, their caregivers and seating therapists to understand how these foot displacements occur and when they become clinically significant. We will use our FootSafe foot pressure and position sensor along with motion capture technology to learn if Veterans with spinal cord injury have more uncontrolled movements of their legs and feet while using wheelchairs compared to people using wheelchairs for other reasons, like bad arthritis. We will also use artificial intelligence to better understand the limb movement data to see if there are early warning signs that the limb will become displaced.